Dynamics of the cellular interactome

Dynamics of the cellular interactome: Abstract;
Through natural selection, protein conformations, interactions and their dynamics inside cells have been
shaped through time to give rise to function needed to sustain life. The set of these intra- and inter-molecular
protein interactions constitute the interactome which defines fundamental functional landscapes that exists
inside living cells. Because selection processes operate within the crowded intra-cellular environment, these
highly evolved interactome networks and the ability to map and visualize them do not exist outside cells. To
overcome barriers and gain insight on cellular interactomes, our lab is developing novel in vivo chemical cross-
linking molecules referred to as Protein Interaction Reporter (PIR) technologies and new mass spectrometry
methods. These developments have provided the initial quantitative in vivo insights on interactomes in live
cells. In this project, we propose to further advance and apply Protein Interaction Reporter (PIR) technologies
together with improvements in accurate mass measurement capabilities that are possible with mass
spectrometry array technologies to gain deeper insight on the cellular interactome. The primary goal driving
our technology advancement is to better understand how interactome dynamics shape functional landscapes
inside cells. Questions we will address include: how are interactome changes among multiple related cellular
phenotypes associated; how do cellular treatments with drugs cause interactome dynamics that affect
pharmacological outcome. Finally, based on our discoveries of interactome changes with Hsp90 inhibitors that
induce heat shock response, we will investigate interactome dynamics during heat and other applied stresses
to reveal which if any inhibitor-induced interactome charges are common to cellular heat shock response
signaling. These efforts may reveal interactome changes that are critical to heat shock response that currently
limit utility of many potent Hsp90 inhibitors.

Public health relevance
Critical processes in cells are carried out through protein interactions that mediate function. This project will develop and apply quantitative in vivo cross-linking and novel mass spectrometry array technologies to gain greater insight on cellular interactome dynamics. These studies will enable improved understanding of human diseases such as cancer, molecular details of how cells alter function during drug treatment, including heat shock response that serves to limit many potential therapies and how cells alter functional pathways to confer chemoresistance.